Input-specific synaptic plasticity in the nucleus accumbens evoked by inhibition of angiotensin-converting enzyme

PROJECT SUMMARY
Substance use disorders (SUDs) impair the health and well-being of over 40 million Americans and claim
106,000 lives each year due to a lack of effective treatments. The nucleus accumbens (NAc), which consists of
medium spiny neurons (MSNs) marked by expression of Dopamine-1 or -2 receptors (D1 or D2, respectively),
is a reward center of the brain that exhibits changes in synaptic plasticity that drive addiction. D1-MSNs drive
rewarding behaviors, such as addiction, while D2-MSNs drive aversive behaviors. Thus, identifying precise
molecular targets that modulate D1-MSN synaptic signaling would hold promising therapeutic potential for SUDs.
Angiotensin converting enzyme (ACE) is selectively expressed in D1-MSNs within the NAc. In the brain, ACE
hydrolyzes numerous neuropeptides, including the enkephalin Met-enkephalin-Arg-Phe (MERF), which has a
high affinity for opioid receptors. ACE inhibition (ACEi) increases levels of MERF in the NAc, which acts in a -
opioid receptor (MOR) dependent manner at excitatory presynaptic inputs to drive long-term depression (ACEi-
LTD) specifically onto D1-MSNs. However, it has not yet been determined which specific excitatory and inhibitory
presynaptic inputs express ACEi-LTD, as NAc MSNs receive a diverse array of long-range excitatory and local
inhibitory inputs.
The main goal of this proposal is to determine which specific excitatory and inhibitory presynaptic inputs
to NAc MSNs express ACEi-LTD, revealing the circuit-specific synaptic plasticity mechanisms evoked by ACEi
which is critical for developing circuit-informed therapies for SUDs. Towards this, excitatory opsins will be
expressed virally in an input and cell type-specific manner in individual inputs to the NAc. Whole-cell patch-clamp
electrophysiological recordings will be taken from D1- and D2-MSNs while optogenetically stimulating individual
excitatory or inhibitory inputs. Optically- and electrically-evoked postsynaptic currents will be measured before,
during, and after application of an ACE inhibitor to determine which specific excitatory and inhibitory inputs exhibit
ACEi-LTD. The MOR-dependence of ACEi-LTD will be determined using pharmacological and genetic blockade
of MOR signaling. Since thalamic inputs to the NAc are known to drive opiate dependence, and since prior
studies suggest that ACEi modulates cortical excitatory inputs to the NAc, Aim 1 will investigate the ACEi
sensitivity of thalamic and cortical excitatory inputs onto MSNs. Additionally, since fast-spiking interneurons
(FSIs) provide the most robust regulation of MSN output, and since low-threshold spiking interneurons (LTSIs)
are known to decrease presynaptic release upon MOR-agonist treatment, Aim 2 will investigate the ACEi
sensitivity of FSI and LTSI inhibitory inputs onto MSNs. This proposal will reveal the circuit-specific effects of
ACEi, which selectively targets D1-MSNs of the NAc that drive reward and contribute to addictive behaviors.
Since ACEi attenuates fentanyl preference in mice, ACE may be a precise and safe therapeutic target for the
prevention and/or treatment of SUDs such as opioid use disorder.

Public health relevance
PROJECT NARRATIVE Synaptic plasticity changes in a region of the brain called the nucleus accumbens underlie the formation of substance use disorders. This proposal will investigate how angiotensin-converting enzyme inhibition, which modulates endogenous opioid signaling, affects synaptic plasticity within specific neural inputs to the nucleus accumbens. This study will further our understanding of the specific cells and neural circuits that will respond to angiotensin-converting enzyme inhibition, which has potential therapeutic applications for the treatment of substance use disorders.